Molecular Mechanisms of Seasonal Time Measurement

PROJECT SUMMARY/ABSTRACT
Failure to respond to seasonal change has severe consequences for an organism’s ability to survive and
reproduce. For humans, seasonal oscillation in the surrounding environment, especially the amount of light,
can cause Seasonal Affective Disorder, as well as cardiovascular and immunity-related diseases. In animals
and plants, reproduction is precisely aligned with specific seasons. Many organisms, including humans, have
evolved sensing mechanisms to prepare for upcoming seasonal changes by adjusting homeostasis, physiology
and development. The long-term goal of our research program is to elucidate the molecular mechanisms by
which organisms measure seasonal changes, particularity in day length and temperature. Although we know
that the interplay between external stimuli (light and temperature) and the internal circadian clock orchestrates
seasonal responses, the molecular regulatory networks involved have remained largely elusive. Seasonal time
measurement has been one of the important topics in chronobiology for decades, and we have learned that
similar types or structures of these networks exist in both animals and plants. Among the model organisms
used in this research, our knowledge of the model plant Arabidopsis is the most advanced. In Arabidopsis,
ambient light and temperature differences are processed through the molecular clock network to regulate the
transcription of a florigen (flower-inducing) gene called FLOWERING LOCUS T (FT). Our major focus is
elucidating how FT transcription is regulated. Although the circadian clock-dependent seasonal sensing
mechanism is the major controller of FT expression, other external and internal information is channeled into
the regulation of FT transcription to precisely determine the timing of flowering. In Aim 1 of this proposal, we
will obtain more precise epigenomic and transcriptomic information in both FT-expressing cells and cells that
do not express FT at the tissue/cell-type levels. With this information, we will be able to organize our current
understanding of FT regulation at the whole plant level into more precise tissue/cell-type specific regulation.
Through our study of plants grown in nature, we recently found an FT transcription regulation controlled by light
and the circadian clock that had been completely uncharacterized up to this point. We will study the molecular
mechanisms underlying this regulation in Aim 2. Our work in seasonal sensing mechanisms has provided
functional knowledge about the photoreceptor FKF1. In Aim 3, we will obtain more precise knowledge about
how this photoreceptor is built by tuning the length of light-excited states and analyzing changes in biochemical
output function. This information will help us understand how the photochemical features of this photoreceptor
control functional outputs; it will also likely provide us with more optogenetic tools. The findings will have a
large impact on plant research and our broader understanding of seasonal sensing and circadian clocks in
mammals and other systems, including humans.

Public health relevance
PROJECT NARRATIVE This proposed research, regarding the molecular mechanisms of seasonal measurement in plants, will bring insight into how organisms extract specific information from the surrounding environment and integrate it into recurring developmental and physiological responses. Failure to respond to seasonal change can have critical impacts on an organism’s survival and reproductive strategies, and on human behavior and metabolism. Knowing the mechanism by which organisms adapt to yearly changing environments will have an implication in improving life quality of plants and animals, including us.